FY21 CONSOLIDATED FACILITIES TASK ORDER C

In accordance with FFRDC SOW, Maintenance plans shall be compatible with elements of the current Interagency Agreement including any revisions thereto, between the U.S. Army Garrison (USAG), Fort Detrick, and the NCI at Frederick with the Contractor performing those functions designated as the responsibility of the NCI at Frederick. The Contractor’s work and responsibility shall include all planning, programming, engineering, maintenance, administration, and management necessary to provide work as specified. The Contractor shall ensure that staffing hours and levels are sufficient to meet the Government’s needs. The work shall be conducted in accordance with the FFRDC SOW, Exhibit 1, Regulations/Certifications/Accreditations/Guidelines.